Research Support Core

ABSTRACT – RESEARCH SUPPORT CORE
This Core Support Center Grant (P30) application requests continued support for an analytical chemistry
laboratory and administrative shared core infrastructure, and support for a pilot project core. The overall aim of
the Research Support Core is to provide a state-of-the-art, well equipped and staffed laboratory resource for
the participating projects of drug abuse researchers at UCSF and at other institutions. Our collaborators
throughout the country require sophisticated analytical chemistry to measure concentrations of drugs, their
metabolites, and biomarkers in order to carry out their research. The objective is to provide support that is
responsive to the needs of constituent scientific projects, as these projects change and evolve. As research
priorities change and new discoveries are made, cutting-edge research requires the development of new
methods. Our laboratory has many years experience in analytical method and biomarker development, is
equipped with state-of-the-art instruments, and a very experienced staff. Developing new methods required for
future collaborative research is a major activity that is supported by our P30 Center. This facility is a cost-
effective shared laboratory resource that enhances and extends research possibilities of investigators currently
funded by NIH or other federal or nonfederal sources to further our understanding of human psychoactive drug
use, abuse and addiction, its health consequences and its treatment management.